DOPAMINE RECEPTOR SYSTEMS AFTER EARLY BRAIN INJURY

This FIRST Award tests the hypotheses that dopamine (DA) is the signal that regulates development of its D1 receptor subtype, and that serotonin (5-HT) regulates the development of striatal D2 receptors after forebrain DA depletion. It is important to understand the above relationships in mammalian brain to provide a framework for understanding attention deficit disorder with hyperactivity and the schizophrenias which, although multifactorial in etiology, may involve damage to developing dopaminergic pathways. This project will investigate the relationships between DA, 5-HT and D1 and D2 receptor development in the DA-depleted neonatal rat, using neuroanatomic, neuropharmacologic, and biochemical techniques. Neonatal DA-depleted rats grow, thrive, and become hyperactive in new environments, but adult DA-depleted rats stop drinking, stop eating, and become bradykinetic. In contrast to adult rats, neonatal DA-depleted rats develop striatal hyperinnervation with serotonergic fibers, and have increased levels of rostral striatal D2 receptors. Data from this laboratory demonstrate marked reductions of striatal D1 receptors in neonatal, but not adult, rats with greater than or equal to 98% DA depletion. Repeated administration of the selective D1 agonist SKF-38393 to neonatal DA-depleted rats restores D1 receptors to control levels. Based on these findings, this project will address whether decreases in DA and increases in serotonin (5-HT) modify levels of D1 and D2 receptors in developing DA-depleted rats with and without 5-HT depletions. This project will also test the hypothesis that levels of D1 but not D2 receptors in neonatal DA-depleted rats can be regulated by treatment with selective D1 agonists. The hypothesis that 5-HT regulates expression of rostral striatal D2 receptors in DA-depleted rats will be further investigated using selective 5-HT antagonists. The proposed studies will help to provide insight into how DA and/or 5-HT may regulate development of DA receptor subtypes during normal development and after selective neurochemical injury.